Co-evolutionary Genetics of Host-Parasite Interactions

PROJECT SUMMARY/ABSTRACT
Long-lived and directly transmitted parasitic animals are among the most potent agents of natural selection
known from human populations. Yet, there is a fundamental gap in our knowledge of the co-evolutionary
mechanisms producing these patterns. This is, in part, because host-parasite interactions are notoriously difficult
to study. Until remedied, progress toward understanding an elusive process that has profoundly shaped our
biology is impeded. New model host-parasite systems are therefore critical for advancing the field. The long-
term goal of our research is to develop and leverage new model host-parasite models for mechanistic studies of
co-evolution. Over the past nearly four years of ESI MIRA support, we have made considerable progress toward
dissecting the genomic basis of the evolution of parasitism and host specialization, and in determining the extent
to which co-evolutionary interactions maintain genome-wide variation in host and parasite populations. The
rationale is that parasitism evolved repeatedly in the lineage that includes the genetic model animal Drosophila
melanogaster. Conveniently, these parasitic flies complete development in the genetic model plant Arabidopsis
thaliana, facilitating in-depth mechanistic study. In addition to addressing our core objectives, the MIRA’s
transformative flexibility allowed pursuit of risky new leads, resulting in a number of fundamental discoveries of
broad interest to biologists. This included characterization of the first odorant receptors specific to volatile
mustard oil toxins (isothiocyanates or ITCs) known in animals, the first use of CRISPR-Cas9 gene editing
technology to fully retrace an adaptive walk in an animal (the mutations sufficient for resistance to cardiac
glycoside toxins in monarch butterflies) using an in vivo knock-in approach, and identification of the first genes
from animals known to encode cytolethal distending toxin (CDT) subunit B proteins, which is our model for the
evolution of toxins used by human immune cells. These discoveries now form the basis of our proposed transition
to EI MIRA support over the next five years. Our specific goal in the next phase of research is to identify the
evolution and mechanistic bases of interactions between hosts and parasites that are mediated by three toxin
classes: ITCs, cardiac glycosides, and CDTs. Three projects already underway that will address this goal are:
(1) the evolution and mechanistic basis of toxin detection by parasites (ITCs), (2) the evolution and mechanistic
basis of toxin resistance by parasites (ITCs and cardiac glycosides), and (3) the evolution and mechanistic basis
of toxin co-option by the immune system (CTDs). This research is expected to inform our understanding of how
toxins of

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it focuses on identifying mechanisms of detection, resistance and co-option of three food-borne toxins of medical importance: isothiocyanates, cardiac glycosides and cytolethal distending toxins. Although these toxins cause human illness, each is also being used or is in development for treatment of common and debilitating diseases, including Parkinson’s disease, congestive heart failure, and cancer. The proposed research is relevant to that part of the NIH mission that pertains to seeking fundamental knowledge about the nature and behavior of living systems and to that part of the NIGMS mission that supports basic research toward understanding how living systems function across levels of biological organization, from molecules, to cells, tissues, individuals and populations.